A Novel-designed sulfonylurea compound for Vascular Dementia Therapy

Summary
Inflammation plays important roles in the progression of vascular dementia, and targeting
inflammation will give a great promise for slowing the progression of vascular dementia and
improving cognitive functions. The nucleotide-binding oligomerization domain (NOD)-like receptor
protein 3 (NLRP3) inflammasome plays a crucial role in regulation of endothelial cell and
microglia-induced inflammation. Elevated NLRP3 expression in microglia has been implicated in
pathogenesis of vascular dementia. Inhibition of microglia-and brain endothelial cell-mediated
inflammation by targeting aberrant NLRP3 activation has emerged as a novel, promising
therapeutic approach for treatment of vascular dementia and other neurodegenerative disorders.
Our preliminary data show that AMS-17, a novel molecule modified from sulfonylurea compound,
has anti-inflammatory effect against LPS-induced inflammation in microglia by inhibiting activities
of the NLRP3. Furthermore, AMS-17 improves cognitive functions and protects neurons from
death in mouse vascular dementia model.
This proposal is proposed to investigate therapeutic effects and elucidate its mechanism of action
using vascular dementia model in mouse. Our goal is to develop a lead molecule for NLRP3
inhibition with high selectivity, adequate metabolic stability, and low toxicity that can be used to
improve cognitive outcomes of vascular dementia. If success, the lead molecule will give a new
effective treatment approach for vascular dementia and other neurodegenerative diseases. The
overall impact of the project is highly significant in advancing drug discovery for brain disease
therapy.

Public health relevance
Project Narrative The proposed project addresses important area of research in vascular cognitive impairment/dementia. The proposed study will explore a new therapeutic approach that targets NLRP3 inflammasomes for therapy of vascular cognitive impairment/dementia. The results of the project will develop a novel lead molecule for the treatment of vascular cognitive impairment/dementia.